Cell-type Specific Interrogation of Variant Function in Alzheimer's Disease

Abstract
Alzheimer’s Disease (AD) affects over 26 million people worldwide, yet the treatment options are limited. This
is in large part due to the unclear molecular mechanisms underlying AD. Genome-wide association studies
(GWAS) have identified genomic regions that are associated with AD, but determining the exact causal variants
and genes remains a major challenge. Recent developments in high throughput genomic technologies have
incredible potential to functionally characterize these causal features, but must be applied to the correct cell
types. Neurons, astrocytes, and microglia are all thought to play key roles in the etiology of AD but obtaining
viable primary human brain cells for these experiments is understandably very difficult. Therefore, recent
protocols to rapidly differentiate human induced pluripotent stem cells into various brain cell types offer great
promise as tools to decipher the genetic basis of AD and guide future therapeutic efforts.
The goal of this project is to identify which AD risk variants alter transcriptional regulatory capacity in human
brain cells and to map them to the genes they regulate. To understand which variants are functional in microglia,
astrocytes, and neurons, I will perform massively parallel reporter assays in human induced pluripotent stem
cells (hiPSCs) differentiated into each cell type (Aim 1). To identify AD risk genes, I will use publicly available
Hi-C, ATAC-seq, and RNA-seq in hiPSC-derived microglia, astrocytes, and neurons to link variants to genes
(Aim 2A). I will functionally validate a selection of putative variant-gene pairs with CRISPR inhibition (Aim 2B).
The results of this work will identify cell-type specific causal variants, and the genes that they regulate. This
will have a positive impact because understanding exactly which genes are involved in which cell types in AD
will elucidate the molecular mechanisms of the disease etiology. The genes identified in this study can act as
targets for future studies and candidates for therapeutic design.

Public health relevance
Project Narrative While Alzheimer’s Disease (AD) is the leading cause of dementia, affecting over 26 million people worldwide, treatment options have been limited due to the unclear mechanism of disease. The proposed research will use genomic data to identify which genetic variants and genes influence AD risk. The results of this study will increase our mechanistic understanding of AD and reveal new genes for further research and drug develop- ment.